Indiana Genomics Research Training Program for Data Scientists (INGEN4DS)

INGEN4DS Project Summary
The Indiana Genomics Research Training Program for Data Scientists (INGEN4DS) will provide practical
training and hands-on research experience in genomics data analysis to prepare and encourage a diverse pool
of talented data science master’s degree students to enter the genomics workforce. As many as eight students
will be recruited annually from master’s degree data science programs at two research-intensive Indiana
University campuses, Indiana University Purdue University Indianapolis (IUPUI), and Indiana University
Bloomington (IUB). Each year, a diverse cohort of underrepresented INGEN4DS scholars will begin the
program in the first week of June with a one-week orientation where the scholars will begin building a sense of
community amongst themselves through social activities; receive training in laboratory safety, responsible
conduct of research, and ethics in genomics research; and attend a poster session to meet the faculty mentors
and learn about available research projects. Weeks 2-7 will consist of two-week rotations in three labs chosen
by the scholar. Each scholar will then be paired with an interdisciplinary co-mentorship team, consisting of one
faculty member in the biomedical sciences who will be responsible for providing a genomics dataset and one
faculty member in computational biology who will supervise the bioinformatics analysis. The scholar, under the
guidance of the mentors, will develop an appropriate research plan involving genomics data analysis that can
be completed within ten months and have a high likelihood of contributing to a publication. Following a needs
assessment, individual development plans (IDP) will be prepared by each scholar in consultation with program
advisors and the co-mentor team to guide the scholar’s training program. The IDP will be reviewed monthly to
assess the scholar’s progress toward their program goals. Professional enrichment activities include practice in
scientific writing and both oral and poster presentations. A seminar series featuring invited speakers from
academia, industry, and healthcare institutions will highlight possible career opportunities in genomics data
science. INGEN4DS scholars will receive stipends for their research efforts during the summer (40 hrs/week),
fall and spring semesters (15 hrs/week), and travel funds to attend one scientific conference to present their
findings. Additionally, the scholars will receive ongoing support including individualized advising, career
development, and assistance in preparing resumes and applications. In the final month of the program,
scholars will prepare a written report and a short oral presentation of their findings. Our expectation is that over
75% of the scholars will secure employment in the genomics workforce or be accepted to a PhD program in
Bioinformatics or a Genomics field. Further, we expect that the scholars will have gained real-world experience
in large-scale genomics data analysis using advanced data sciences methodology and computing resources
and will have achieved effective communication skills necessary for working in interdisciplinary genomics
research groups.

Public health relevance
Project Narrative The long-term goal of the Indiana Genomics Research Training Program for Data Scientists (INGEN4DS) is to increase the diversity of the genomics workforce by producing well-trained data scientists with genomics expertise. Training will be available for 8 students each year with the goal of these students joining the genomics workforce or matriculating into PhD programs in genomics. This goal will be accomplished by providing hands-on training with genomics data and participation in state-of-the-art genomics research in areas relevant to human health, such as cancer and rare genetic diseases.